Core B: Developmental

Modified Project Summary/Abstract Section

The goal of the Developmental (Dev) Core (Core B) of the Emory CFAR is to develop the next generation of outstanding HIV investigators. The Dev Core takes an innovative, holistic approach to investigator development that builds on an integrated set of services, support, opportunities, and referrals that are designed to assist early-stage investigators (ESIs) and established scientists new to HIV research to obtain funding and connect with CFAR mentors and collaborators, services, and resources. Core users will be supported and encouraged to use any of the Dev Core services that will help advance their science and their career in HIV research. Dev Core users will also be introduced to the full range of CFAR Science Core services, encouraged to participate in the CFAR Scientific Working Groups as appropriate, and informed of all CFAR-hosted programs and seminars, including the monthly Emory CFAR Synergy Seminar series. In the next project period, the Dev Core will continue to build on successful programs and add new initiatives that extend the Core’s reach and fill identified gaps in service, such as systematic pre-submission review and research idea design thinking. Dev Core activities will emphasize team science, innovative methods for community engagement in study development, and effective partnerships with Emory-wide grant development offerings to encourage collaboration and to increase impact. The Core will employ regular evaluation of its activities to inform the extent to which services meet the needs of mentees and to provide opportunities for process improvement throughout the award period. The Emory CFAR Developmental Core will accomplish its goals through the following specific aims: Aim 1. Offer research funding opportunities to promote individual and team science, to elevate community engagement, and to expand the number of funded HIV researchers. Aim 2. Implement proposal development activities to increase the competitiveness of HIV research applications submitted to the NIH. Aim 3. Provide mentoring for early-stage investigators, as they transition from trainee to independent investigator, through structured research resources and support. Aim 4. Support professional development activities to assist CFAR Members in cultivating new or enhanced expertise in research and multiple modes of science communication.